The Impact of COL6A3 Mutation on Inflammatory Susceptibility in Osteoarthritis

PROJECT SUMMARY
Osteoarthritis (OA) is a painful and debilitating joint disease affecting over 30 million people in the United States
alone. OA is characterized by the progressive degeneration of cartilage matrix primarily due to an imbalance of
chondrocyte catabolic and anabolic activities arising from genetic, chemical, and mechanical risk factors. Current
non-surgical treatments for OA rely simply on managing symptoms primarily owing to a lack of a full
understanding of the molecular mechanisms leading to disease onset and pathogenesis. In recent exome
sequencing studies, genetic mutation in collagen type VI alpha three (COL6A3) has been identified to increase
risk of developing early-onset OA. COL6A3 encodes for one of the proteins that forms collagen type VI (COL6),
a critical component of the chondrocyte’s pericellular matrix (PCM). COL6 is a key mediator of the chondrocyte’s
transduction of chemical and mechanical cues by maintaining the structural integrity of the PCM. It is likely that
mutation in COL6A3 may exacerbate OA by altering PCM properties; however, the mechanisms leading to
disease remain unknown. In this proposal, we will determine the molecular link between COL6A3 mutation and
OA etiopathogenesis. We hypothesize that COL6A3 mutation increases the effect of inflammation on
chondrocyte catabolism and PCM degradation, leading to alterations in the normal chondrocyte
metabolic response to mechanical loading thereby initiating a cycle of cartilage degeneration. To
complete the proposed studies, we have developed a novel in vitro “OA-in-a-dish” disease model using human
induced pluripotent stem cell (hiPSC)-derived chondrocytes gene-edited to introduce the COL6A3 mutation. In
specific aim 1, we will assess the effects of proinflammatory cytokines on the biological and mechanical
properties of hiPSC-derived cartilage with and without the COL6A3 mutation. Then, in specific aim 2, we will
determine the effect of this mutation on chondrocyte mechanotransduction following proinflammatory cytokine
treatment. This proposal aims to determine a mechanistic cause for increased predisposition to early on-set OA
due to mutation in COL6A3, that can be used for the identification of targets for therapeutic development.
Completion of these studies will better define the mechanisms that mechanical, genetic, and biochemical factors
act in concert and lead to OA.

Public health relevance
Project Narrative Osteoarthritis (OA), the most common joint disease, leads to severe pain and disability primarily due to altered chondrocyte mechanotransduction and increased joint inflammation. Exome-sequencing studies have identified a mutation that increases risk of developing early on-set OA in COL6A3, a critical component of the chondrocyte’s pericellular matrix (PCM). While it is likely that the effects of this mutation are due to changes in the properties of the PCM, the etiopathogenesis remains unknown. This project will determine the mechanistic link between COL6A3 mutation and OA by investigating how this mutation affects the PCM’s susceptibility to inflammation-induced degradation and chondrocyte catabolism, along with determining alterations in chondrocyte mechanotransduction.